Enzyme-Mediated Depletion of Extracellular Adenosine and 5'methylthioadenosine as a Novel Anti-Cancer Therapeutic

PROJECT SUMMARY
In recent years, adenosine has been identified as an important therapeutic target due to its observed
immunosuppressive effects in the tumor microenvironment. By agonism to adenosine receptors, adenosine
is a broad suppressor of immune function, decreased cytotoxic activity of T cells and NK cells, and increased
differentiation of T cells to T regulatory cells. In the tumor microenvironment adenosine are elevated due to
the overwhelming release of adenosine triphosphate and nicotinamide adenine dinucleotide, both of which
are degraded to adenosine in the extracellular environment during cancer-associated stress conditions.
Structurally similar 5’methylthioadenosine, and adenosine’s extracellular degradation product inosine are
also observed to stimulate adenosine receptors. Independent of immunomodulatory mechanisms, tumor-
expressed adenosine receptors have been observed to contribute to growth, metastasis, and proliferation of
cancer cells. This effect is less defined compared to the immunosuppressive activities, but has significance
in both solid tumors and post-chemotherapy or radiation models where adenosine and inosine are often
greatly elevated due to surrounding dead or dying cells.
Individual cancer cell lines commonly delete the gene encoding methylthioadenosine phosphorylase,
responsible for depleting 5’methylthioadenosine, and are separately observed to modulate the expression of
enzymes responsible for producing or degrading adenosine, or expression of adenosine receptors. The
varied and redundant pathways resulting in adenosine receptor stimulation limits the effectiveness of single
receptor agonists or enzymatic inhibitors. For this reason, in Aim 1 I will engineer a stable, high affinity human
methylthioadenosine phosphorylase which substantially degrades both adenosine and
5’methylthioadenosine. Engineering an enzyme with favorable kinetic parameters, selectivity, and stability
will allow for therapeutic characterization. In Aim 2, I will evaluate the in vitro efficacy of the enzyme and
immune-independent mechanism with human cancer cell lines. Finally, in Aim 3 I will perform in vivo analysis
of therapeutic potential. Following toxicology and pharmacologic studies, I will define the therapeutic effect
on a the CT26 colon carcinoma syngeneic murine cancer model. I will use CD4 and CD8 T cell depletion
and tumor immunophenotyping to gain insight into the immunomodulatory mechanism, specifically the
balance of effector versus regulatory lymphocytes.

Public health relevance
PROJECT NARRATIVE Adenosine-receptor stimulation by adenosine and structurally similar molecules including 5’methylthioadenosine has well-documented immunosuppressive properties in human solid tumors. It is hypothesized that enzymatic adenosine and 5’methylthioadenosine depletion with engineered human methylthioadenosine phosphorylase (hMTAP) can (a) offer a better therapeutic option in certain cancers when compared to the molecules already in clinical trials, and (b) offer further insight into the mechanism of action. This investigation will first increase hMTAPs slight affinity for adenosine to therapeutically relevant catalytic efficiency through methodical library design in order to test the effective depletion in vitro and in vivo, then focus on mechanistic evaluation by examining both the immune-independent influence of adenosine and its degradation products, and the balance of immunomodulatory mechanism of effector versus regulatory T cells.